Center for Transformative Infectious Disease Research (CTIDR)

The Administrative Core (AC) has primary responsibility for overseeing and facilitating all
aspects of the Center for Transformative Infectious Disease Research (CTIDR). These
duties encompass both the Center’s transdisciplinary, community-engaged research and
its research capacity building. As such, the AC will house the Center’s leadership,
including PI Dr. Alexander Travis, lead administrator, Angela Downing, and a program
manager. The AC will provide structure/ support to test the Center’s overall hypothesis,
that community-based research that integrates diverse kinds of data will drive the
development of predictive epidemiological models. These will in turn enable the design
and rigorous testing of preventative interventions–a transformative shift from responding
to outbreaks to preventing them before they occur. To realize CTIDR’s ultimate goal, the
AC must fulfill its functions of ensuring efficient administrative and organizational
operations. The AC will accomplish this mission through performance of three Specific
Aims. First, the AC will provide oversight/governance as a whole, guiding our science to
ensure that it is community-engaged, transdisciplinary, and impact-oriented. We will
manage our External Advisory Committee and self-evaluation processes, and manage
and deploy the Center’s financial and personnel resources. Second, we will ensure
timely and efficient flow of scientific information across all components of the Center, and
from the Center to external stakeholders. To create the kinds of predictive models that are
our goal, we must integrate social, weather, land-use, animal and human health, and
vector and pathogen genomic data. To have these models be actionable, and approaches
disseminated broadly, we must ensure that they are informed by both the rural
communities with whom we work, and policymakers who might use them. Third, a major
objective of the P20 mechanism is to build research capacity. Toward this goal, the AC will
run competitive pilot grant and Rapid Response Fund grant mechanisms that will favor
Early-Stage Investigators. These grants will enable junior faculty to test feasibility of
ideas, generate preliminary data, and demonstrate ability to have productive
partnerships and community engagement. Lastly, the AC will run a training program
focusing on graduate students, post-doctoral associates, and Early-Stage Investigator
faculty. This program will enable junior scientists to create transdisciplinary networks and
learn the “soft skills” that are essential for health research and impact, such as
communicating with audiences ranging from the public to government and the private
sector, and across disciplines/professions. Although a focus of our training program,
communication and partnership are key principles that guide all the AC’s activities